An Open Web Service For Fragment-based Design of Small Molecule Inhibitors

Abstract
Significance. BMaps™, our fragment-based drug design (FBDD) web application, is a comprehensive tool that
empowers chemists in designing small molecules and prioritizing them for chemical synthesis. The
transformative impact of FBDD derives from efficiently discovering new chemistries that can exploit the fine 3D
details of protein binding surfaces, unlike other molecule screening methods. Further, FBDD enables
combinatorial exploration of large chemistry spaces by growing fragments at multiple R-group sites on a
molecule. This Phase IIB application has three aims to advance BMaps. By harnessing the power of AI language
technologies (e.g. ChatGPT) and incorporating knowledge from building blocks and synthesis schemes from
ultra-large chemical libraries such as Enamine and eMolecules, we aim to substantially accelerate drug design
workflows and provide tools to generate new ideas for better drug candidates. The design of compounds with
optimal affinity, synthetic accessibility, and physicochemical properties is achieved while reducing the workflows
from hours to minutes. Innovation. BMaps' core innovation lies in fragment and water maps created from
BMaps' GCMC-SACP fragment simulations (Boltzmann maps), which are mined by a geometric search algorithm
for optimal compound modifications ranked by binding free energy. This robust framework ensures design
efforts that are both expansive in chemistry space and firmly rooted in the principles of statistical mechanics.
BMaps will distinguish itself by introducing the first reaction-aware and AI-driven FBDD platform. The proposed
extension of our geometric search uses reaction-annotated fragment maps and desired drug properties to
radically prune the compound search space compared to affinity-only pruning. These advances of in silico FBDD
position our platform to capture a larger market share, boosting sales and user adoption. Approach. First, we
will extend chemistry-aware algorithms to dissect chemical building blocks from vendor libraries into
simulation-ready fragments, annotated by known reactions. Second, we will incorporate reaction selection and
compound filtering interfaces for specifications used in enhancing the efficiency and accuracy of fragment grow
searches. Third, we will extend our text and voice AI Large Language Model (LLM) powered tool, Gibbs™, to
learn and automate user workflows, and provide expert guidance throughout the design process.
Commercialization. By accomplishing these aims, BMaps will have significantly enhanced utility and
accessibility that enable the use of FBDD in designing better molecules to a much larger audience. These
advancements will bridge the gap to full commercialization, empowering medicinal chemists to efficiently design
and prioritize high-affinity, synthesizable compounds with optimal PK properties. BMaps is among the vanguard
of the next-generation AI-powered drug design tools.

Public health relevance
Project Narrative. The grant proposes enhancements to BMaps, a fragment-based drug design web application, to significantly accelerate molecule design workflows. The key improvements include integrating synthetic feasibility into compound design, incorporating physicochemical properties into fragment grow searches, and extending AI- assisted guidance to complex workflows. By accomplishing these aims, BMaps will have significantly enhanced utility and accessibility, bringing the strengths of FBDD in designing better molecules to a much larger audience.